EPIDEMIOLOGY OF DIABETES INTERVENTION AND COMPLICATIONS (EDIC)

The DCCT demonstrated that intensive diabetes management reduced the risk of development of early diabetes complications by 50-75%. This study will examine the long turn outcomes in patients with the DCCT with special emphasis on the development of microvascular endpoints.